Community Engagement Core

COMMUNITY ENGAGEMENT CORE
SUMMARY/ABSTRACT
The Community Engagement Core (CEC) will build bidirectional partnerships with target communities to enhance
understanding of the health risks posed by emerging water contaminants in the environment (specifically 1,4-
dioxane (1,4-DX)), and to provide interventional strategies that will improve public health and inform health policy.
In the first phase of the project, the CEC will focus on communities in Nassau and Suffolk counties of Long
Island, New York. These communities include residents whose public drinking water wells are impacted by
nearby EPA Superfund sites. The CEC will work with the Research Translation Coordinator (in the Administrative
Core) to develop replicable tools and resources to provide data and generate knowledge among stakeholders
who are invested in addressing water-related issues in the State of New York, especially in areas near Superfund
sites. To accomplish this, we will identify effective methods to communicate risk information to each stakeholder
group, including the economically-disadvantaged and environmental justice communities proximal to these sites.
The specter of emerging contaminants in drinking water is fraught with uncertainty about risk and appropriate
courses of action, creating an atmosphere of confusion, blame, anxiety and, most importantly, mistrust. The CEC
will address these challenges through facilitation of engagement and information exchange among the diverse
and relevant constituencies in NY. We will create opportunities for constituent groups, including federal, state
and local governmental agencies, to learn from each other and share information. We will encourage and
facilitate multi-directional interactions among communities and experts to complement and support the Yale
Superfund Research and Training Program’s (YSRTP’s) overarching objective of fostering research that
improves the exposure assessment, health evaluations, and mitigation of emerging contaminants in drinking
water in EPA Regions 1 (New England) and 2 (New York, New Jersey, Puerto Rico, US Virgin Islands and eight
Tribal Nations) and North Carolina. In addition, we will collaborate with the Research Experience and Training
Coordination Core (RETCC) to educate and train the next generation of scientists to conduct citizen science and
develop skills for advocating for environmental justice and equity. The initiatives implemented in this proposal
will be transferable to other communities facing similar challenges including the State of New Hampshire, which
will be the second targeted area for CEC activities. We will also be sharing our findings and experience with the
North Carolina State University Superfund Center, which is collaborating with the YSRTP’s research projects.
The overarching goal of the CEC is to engage, educate and empower residents in impacted communities so
they may understand and inform public health policy, and participate in the improvement of public health. Results
of this collaborative effort will have a significant impact on the health of human populations in New York and New
Hampshire, aid the resolution of similar challenges at Superfund sites throughout the U.S.A., and enhance global
efforts to monitor, remediate and determine the impact of water contaminants.

Public health relevance
PROJECT NARRATIVE The uncertainty about risk and appropriate courses of action surrounding emerging contaminants in drinking water, such as 1,4-dioxane (1,4-DX), creates an atmosphere of confusion, blame, anxiety and mistrust in communities impacted by these issues. The focus of the Community Engagement Core (CEC) in the Yale Superfund Research and Training Program (YSRTP) is to address these challenges through facilitation of engagement and information exchange among diverse constituencies in two states currently impacted by 1,4- DX issues (i.e., New York and New Hampshire). The CEC will create opportunities for stakeholders – including residents, government agencies, community and educational organizations – to learn from each other, and by utilizing multilateral partnerships among the projects in the YSRTP, will strengthen relationships across stakeholder groups, foster educational opportunities, and promote active and sustained community engagement.